BLRD Research Career Scientist Award Application

Project Summary/Abstract
Current research activities in the laboratory of the Nominee concentrate on repetitive mild traumatic brain injury
rmTBI), Gulf War Veterans' Illnesses (GWVI), and substance abuse disorders (SUD). Each of these conditions
has in common damage to the brain. These conditions can also interact and serve as a co-morbid condition for
the others. These illnesses are over-represented in Veterans and represent serious health concerns for them
and their families. There are no effective therapies for rmTBI, GWVI and SUD. The overarching goal of this
research program is to achieve a better mechanistic understanding of rmTBI, GWVI and SUD so that
evidence-based therapies can be developed which will restore and return brain function in Veterans with these
disorders. rmTBI is a complex and chronic condition that has remained untouched by therapeutic interventions.
Despite numerous treatment successes in animal models, all clinical trials of TBI therapies in humans have
failed to date. This situation can be attributed to inappropriate animal models, at least in part. This project will
use a new mouse model of rmTBI that closely mimics the human condition insofar as symptoms and
pathologies in brain develop very slowly. Treatments directed at arresting increased glial reactivity will be
started after head impacts have been completed in order to maintain a translational approach. GWVI is another
chronic condition in Veterans of the Gulf War and this condition is characterized by three main symptom
clusters- gastrointestinal disorders (like IBD), chronic fatigue, and anxiety/PTSD-like conditions. Perhaps the
largest obstacle to achieving better treatments for GWVI is the fact that the toxins to which military personnel
were exposed are not known (dose, length of exposure, combinations). This project recognizes that all three of
the major symptoms of GWVI can be traced one-by-one to an altered gut microbiome. It also recognizes that
any toxins to which military personnel were exposed have been eliminated from their bodies soon after they
redeployed home. Therefore, we hypothesize that lifestyle risk factors, common among Veterans (e.g., obesity,
smoking, alcohol abuse), all of which can also disrupt the gut microbiome, interact with these exposures to
accentuate and prolong symptom expression. Research on this project will therefore target the gut with
therapies intended to correct the gut microbiome disruption that results from GWVI-lifestyle interactions (e.g.,
probiotics, short chain fatty acids, microbiota-accessible carbohydrate and/or low-fat diets). A second phase of
this project will develop a humanized mouse model of GWVI by transferring the diseased gut microbiome from
Veteran donors into mice and examining the mice for symptoms of the human disorder. This project bypasses
the uncertainly regarding toxin exposure in GWVI and will incorporate an important complicating factor in this
disorder- human GWVI shows much more symptom variability than the mouse model. This individualized
medicine approach will then target specific treatments aimed at symptom reduction. Finally, it is emerging that
Veterans with rmTBI and GWVI are at risk for co-morbid SUDs. This project will therefore examine opiate use
in models of rmTBI and GWVI using oxycodone self-administration. Oxycodone is the most abused
prescription drug worldwide and has become infamous in the opioid overdose epidemic. New research in our
lab has shown that oxycodone self-administration causes significant disruptions in the gut microbiome.
Therefore, we will extend the rmTBI and GWVI projects to incorporate tests of oxycodone abuse. It is
hypothesized that animals with rmTBI and GWVI will self-administer significantly greater amounts of
oxycodone and cause further disruptions of the gut microbiome. Attempts to rebalance the gut microbiome in
these conditions will be tested as therapies. These studies have been made possible by generous support
from VA-funded instrument grants.

Public health relevance
Project Narrative The Nominee's projects involve the study of repetitive mild traumatic brain injury (rmTBI), Gulf War Veterans' Illnesses (GWVI) and substance abuse disorders (SUD). These conditions are chronic, the symptoms worsen over time, they are associated with numerous co-morbid disorders, and there are no effective treatments for them. rmTBI and GWVI are often associated with SUDs, particularly opiate drugs. Opiate abuse represents a significant problem by itself, and can increase the risk of overdose, but it compounds the problems associated with rmTBI and GWVI. It is known that rmTBI, GWVI and SUDs can significantly alter the gut microbiome so it is important to understand if these conditions can be improved by rebalancing the disease-altered gut microbiome. Work on this project will capitalize on prior VA instrument grant support that allowed our lab to acquire automated, high-throughput instrumentation to analyze the gut microbiome. This project is highly relevant to Veterans health and to the VA healthcare mission.